Exploring brain perivascular fibroblasts in health and cerebral amyloid angiopathy

PROJECT SUMMARY
Maintaining a stable brain vascular network is crucial for ensuring overall brain health throughout life.
Perivascular cells, like pericytes and smooth muscle cells, are crucial to maintain the integrity of the brain
vasculature. Loss of pericytes and smooth muscle cells are noted in Alzheimer’s Disease (AD) and affects
vascular integrity, ultimately contributing to disease pathology. Perivascular fibroblasts (PVFs) are another cell
population along the brain vasculature, however their role is largely unknown. PVFs express numerous
extracellular matrix proteins that are uniquely found on arterioles and venules but not capillaries. My preliminary
investigations indicate that PVFs maintain vessel structural stability, particularly along arterioles, in the healthy
brain. Further, I find that arterioles are more tortuous in a mouse model of cerebral amyloid angiopathy (CAA),
and this is associated with a significant reduction in PVFs. CAA is a small vessel disease characterized by the
accumulation of amyloid- on vessels commonly observed in AD. Arterioles and their immediate off-shoots are
important major regulators of blood flow into the brain. In doing so, they undergo extensive dilation and
constriction events which is likely supported in part by extracellular matrix proteins expressed by PVFs. The goal
of this proposal is to determine if PVFs regulate arteriole structure and dynamics in the healthy brain.
Further, my goal is to understand if CAA contributes to PVF loss, altering arteriole structure and
dynamics by affecting the expression of extracellular matrix proteins, ultimately exacerbating CAA.
Understanding these important aspects of the brain vasculature could ultimately provide a potential for
developing therapeutics aimed at limiting AD pathology and improve vascular function.
The training I will receive under the guidance of Dr. Andy Shih, who is an expert in in vivo imaging and brain
vascular physiology in health and disease, will enable me to achieve the goals of this proposal. My training is
further supported by my advisory committee, consisting of Drs. Steven Greenberg, Richard Daneman, and
Timothy Cherry who will enhance my training by providing guidance in CAA clinical pathology, PVF pathobiology
and single-cell transcriptomics, respectively. Upon completion of these studies, I will have gained extensive
knowledge of in vivo imaging, complex vascular physiology and single-cell transcriptomic approaches, in addition
to PVF biology in heath and CAA pathology. These foundational studies and techniques are crucial components
of my proposed independent phase described in this application and will propel my future goals of running an
independent research group studying small vessel diseases in the brain. Further, with the support of Dr. Shih,
my advisory committee, and the faculty at Seattle Children’s Research Institute in the Center of Developmental
Biology and Regenerative Medicine, I will have expanded my experience in scientific communication,
grantsmanship, networking, and mentorship. By continuing to strengthen these crucial skills during my training
phase I will be well poised to guide a successful research group of my own.

Public health relevance
PROJECT NARRATIVE Vascular dysfunction is commonly observed in the small vessel disease, cerebral amyloid angiopathy, and contributes to the neuropathology of Alzheimer’s Disease. Utilizing live-imaging and transcriptional studies in mice, I seek to identify how perivascular fibroblasts support the brain vasculature and how their loss in cerebral amyloid angiopathy contributes to vascular dysfunction. Identifying how perivascular fibroblasts support brain vascular function is crucial to develop therapies that improve vascular function and limit tissue damage in Alzheimer’s Disease.